Effects of EBV Type on Viral Reactivation

PROJECT SUMMARY / ABSTRACT
Epstein-Barr virus (EBV) causes infectious mononucleosis and is an important cause of human B-cell and
epithelial cell cancers. The switch between latent and lytic infection is mediated by two viral immediate-early (IE)
proteins, BZLF1 (Z) and BRLF1 (R). There are two types of EBV, type 1 (T1) and type 2 (T2), but relatively little
is known about T2 EBV. T2 EBV is impaired for the ability to transform B cells in vitro due to decreased
expression of an EBV oncoprotein, LMP1. However, our preliminary studies demonstrate that T2 EBV induces
B-cell lymphomas in a humanized mouse model that are highly lytic, and is also more lytic in oral epithelial cells.
Thus, we hypothesize that enhanced lytic infection is a major phenotype of T2 EBV. Our analysis of publically
available EBV genomes indicates that all T2 EBV share the same variant (Zp-V3) of the viral promoter (Zp) that
governs whether EBV infection is latent or lytic in B cells, and also contain the same variants of the Z and R IE
proteins. The T2-encoded Z protein contains 9 amino acid (aa) differences compared to Z encoded by T1 viruses,
all located within functionally important regions of the 245 aa protein. Neither the functions of the T1 versus T2
forms of Z, nor the activities of theT1 versus T2 forms of the Z promoter, have been compared. Both the T2 form
of the Z promoter, and the T2 form of the Z protein, have been reported to be over-represented in certain types
of EBV-infected cancers relative to their frequency in non-malignant samples, and we have recently discovered
that T1/T2 hybrid viruses (containing the T2 form of the Z/R IE locus within otherwise T1 EBV viruses) are over-
represented in EBV isolated from Burkitt lymphomas (BLs). We have also discovered that the T2, but not T1,
form of the Z promoter confers enhanced lytic EBV reactivation in antigen-stimulated B cells due to its ability to
bind the NFATC1 cellular transcription factor, and our preliminary results indicate that the T2 Z/R proteins also
have an enhanced ability to induce lytic reactivation in B cells. We hypothesize that T2 EBV strains are much
more lytic than T1 EBV strains due to differences in the Z promoter, the Z and/or R IE proteins, and decreased
LMP1. We also hypothesize that hybrid T1/T2 EBV strains (containing the T2 form of the Z/R IE locus) have an
increased ability to enter lytic infection relative to pure T1 strains, and that this difference enhances their
malignant potential. Our Specific Aims are to 1) use a humanized mouse model to define EBV genes contributing
to the enhanced lytic phenotype of T2 EBV infection in B cells, and to determine if a hybrid T1/T2 EBV virus
resembling hybrid viruses found in human BLs is more lytic, or more transforming, than pure T1 EBV; 2) compare
the phenotypes of T1, T2, and T1/T2 hybrid viruses in undifferentiated and differentiated oral epithelial cells, and
3) compare the functions of the T1 versus T2 Z and R proteins, and T1 versus T2 Z and R promoters, in vitro in
B cell and epithelial cell models, and define mechanism(s) for any differences. The proposed studies should
expand our understanding of T2 EBV, and may reveal why T1/T2 hybrid EBV strains are over-represented in
cancers.

Public health relevance
PUBLIC HEALTH RELEVANCE Epstein-Barr virus (EBV) causes infectious mononucleosis and is an important cause of human malignancies, including B-cell lymphomas and nasopharyngeal carcinomas. There are two types of EBV, Type 1 (T1) and Type 2 (T2), but very little is known about T2 EBV. Lytic EBV infection leads to infectious virus production, and our preliminary results suggest that T2 EBV is much more lytic than T1 EBV. We have also discovered that hybrid T1/T2 EBV strains containing T1 latency genes, but a T2 lytic regulatory locus, are over- represented in human lymphomas. In this proposal, we will use a humanized mouse model, and an oral keratinocyte model, to compare T1 versus T2 EBV infection, and will also determine if a hybrid T1/T2 EBV similar to that found in human lymphomas is more lytic and/or more transforming than pure T1 EBV. These studies should reveal key differences between T1 and T2 EBV, and may identify mechanisms that lead to selection for T1/T2 hybrid EBV genomes in lymphomas.